Interventional method development for multiplexed personalized drug evaluation using implantable microdevices

Abstract: Novel implantable miniaturized devices (IMDs) placed directly in patient tumors can rapidly evaluate
multi-drug responses in-situ. They can be used in any solid tumor to provide direct, comprehensive, spatial multi-
omic readouts of >20 drugs simultaneously, with potential to eclipse liquid and tissue biopsy biomarker
capabilities. However, placing and retrieving IMDs in tumors currently requires highly invasive surgery with
excessively high patient morbidity and complication risks. For most cancer patients, these risks are prohibitive,
and as a result ongoing first-in-human IMD trials have had limited enrollment.
We have developed a fully interventional (minimally invasive) non-surgical method to place and retrieve
IMDs. We use custom needle biopsy devices and image guidance to deliver and precisely remove only the IMD
and adjacent drug-exposed tissue. This is a simple outpatient procedure similar to routine percutaneous tumor
biopsies, using a single tiny (<2mm) skin incision. It reduces the morbidity and risks of IMD use, and would
greatly increase enrollment in current and future clinical IMD trials. However, a preclinical study in an animal
model is needed to demonstrate technical feasibility and safety of this interventional method prior to first-in-
human use.
This proposal describes a preclinical study in a rabbit hindlimb tumor model that closely simulates a
typical soft tissue sarcoma setting, with the following specific aims: 1) determine the technical feasibility of our
interventional (non-surgical) approach for IMD-placement and retrieval; and 2) determine the overall safety and
adverse event rate of this same interventional method. Interventional IMD placement and retrieval procedures
will be performed in a statistically-powered cohort of 15 rabbits. Technical feasibility and safety endpoints will be
assessed, and used to inform further method refinement and ultimately first-in-human trials.
The proposed study is innovative as it will develop and validate new interventional tools for personalized
cancer treatment that could serve as the next generation of tumor biopsy. It is significant as it will directly enable
a first-in-human trial to evaluate IMD-based drug optimization in patients with advanced soft tissue sarcomas. It
will also enable greater enrollment in ongoing IMD clinical trials in other similar or lower risk anatomic regions
(e.g. breast). Ultimately, if the overall long-term goal of clinically validating IMD-based personalized treatment
optimization is achieved, the interventional methods developed here could be applicable to every oncology
patient with a percutaneously accessible tumor (similar to routine percutaneous tissue biopsies).

Public health relevance
Narrative This project seeks to validate an interventional radiology approach to non-surgically deliver and retrieve implantable microdevices (IMDs) designed to rapidly test multiple drug responses directly within a live tumor in its native environment. This approach is less invasive and more practical compared to current surgical methods of IMD delivery, and provides a more comprehensive and direct assessment of drug response compared to current biomarker-based personalization strategies. If successful, it could enable clinicians to screen and optimize personalized cancer treatments in nearly all patients with solid tumors.